COMPARING ANTIRETROVIRAL THERAPY PLUS ARA-C FOR TREATING PCP IN HIV

This study is to evaluate the safety and effectiveness of cytosine arabinoside and the antiretroviral medications zidovudine, didanosine, and zalcitabine for the treatment of progressive multifocal leukoencephalopathy.